AnVIL Clinical Environment for Innovation and Translation (ACE-IT): Supplement for Clinical Data Integration meeting

PROJECT SUMMARY
The Analysis, Visualization, and Informatics Lab-space (AnVIL) platform is a scalable cloud-based
computing resource that aims to accelerate genomics research by providing broad access to
genomics datasets and the infrastructure necessary to improve analysis workflows and enhance
collaboration. The AnVIL Clinical Environment for Innovation and Translation (ACE-IT)
project will bring together a network of expertise to address a major gap in clinical genomics
research and operationalize a key mission of the AnVIL project by expanding its existing
ecosystem to include a comprehensive suite of clinical genomics research tools and services.
The newly developed AnVIL Clinical Resource will bring together data, tools, and support
resources meant to amplify the benefits of the existing platform and provide a critical foundation
for the clinical genomics research community to better leverage this innovative resource.
Development of the ACE-IT will be guided by three key aims: 1. Engagement with diverse
community and research partners to characterize barriers and facilitators to adopting federally-
supported, cloud-connected clinical genomics research services; 2. Development and
deployment approaches to ingest, index, and search data to support clinical genomics research
with an emphasis on populations historically underrepresented in biomedical research; and 3.
Integration of tools, APIs, and workflows that enable clinical genomics research methods on the
AnVIL, including rare disease diagnosis and genomic risk scores as use cases. The ACE-IT team
consists of expertise across multiple health care centers, including Vanderbilt University Medical
Center, Brigham and Women's Hospital, Massachusetts General Hospital, and the American
Heart Association. This team will develop infrastructure on AnVIL's cloud environment to meet
clinical genomics researchers' needs over time and integrate with existing AnVIL working groups
and meetings as team members and stakeholders where appropriate. The tools and resources
we develop will support clinical genomics research by focusing on both rare and common
diseases and integration into translational research.

Public health relevance
PROJECT NARRATIVE The Analysis, Visualization, and Informatics Lab-space (AnVIL) is a cloud-based computing platform that brings together genomics resources and broad access to genomics datasets to enhance collaboration across research teams. The AnVIL Clinical Environment for Innovation and Translation (ACE-IT) team will amplify the existing AnVIL platform by first engaging with diverse partners to characterize barriers to clinical genomics research on cloud environments integrating tools that enable clinical genomics research methods. The team will then work with existing AnVIL teams and partners to integrate diverse datasets and implement clinical genomics tools to support the rapidly evolving field of clinical and translational genomics research.